Development of MR-derived parameters of LV diastolic function: Validation and Comparison to LV and LA fibrosis

Project Summary
The clinical impact of this proposal is the development of cardiac MR methods for evaluating diastolic function
and determining how it relates to left ventricular and left atrial fibrosis. We will test the hypothesis is that pre-
existing ventricular and atrial fibrosis (diffuse fibrosis) may be reflected in increased atrial pressures, or in other
diastolic parameters of chamber compliance, which can be evaluated using these new methods. We also
hypothesize that diastolic parameters and LV and LA diffuse fibrosis will be independent important predictors
of new onset AF. There is a wealth of evidence that atrial fibrosis, heart-failure with preserved EF, and new
onset AF are a constellation all strongly associated with each other, and with diastolic dysfunction. The
development of tools for measuring diastolic function will have enormous impact in patient care.
The goals of this proposal are to develop a method for easily processing cine images to yield e', the
early diastolic velocity of the mitral valvular tissue region, using feature tracking methods. Further, the goals
are to develop and test methods for simple and robust E and A measurements of blood flow through the mitral
valve, and to develop methods for measuring pulmonary vein inflow. The validations will proceed in healthy
subjects and then 110 patients. The reproducibility will be included.
The innovation of this grant is the recognition that diastolic function is critical-- in conjunction with the
recently developed capabilities of measuring left ventricular diffuse fibrosis with and MRI, and left atrial
volumes, strain, and fibrosis-- in understanding the relationship between atrial pressure during diastole and left
atrial remodeling. We further propose innovative MR methods, including a black blood cine method, which will
generate cine images to visualize the valves more clearly, and might have further applications. We propose
the use of slice-following with phase-contrast, which is already established, but will combine it with feature-
tracking to vastly improve its clinical feasibility.
We have assembled a team including an MRI Physicists with expertise in novel acquisition and
reconstruction, non-invasive cardiologists and a radiologist who will guide the translational studies, and a multi-
modality cardiologist who is expert in animal models of disease, for correlating MR measurements of diastolic
function with invasive pressure measurements. The PI is a pioneer in the area of left atrial evaluation, for
which diastolic function is a major influence. Together, working on these Aims, we will develop a new
approaches for evaluating diastolic functional parameters, E, A, e' and more, and define their role in
development of atrial fibrillation.

Public health relevance
Narrative Patients often develop short-lived arrhythmia (atrial fibrillation) early after cardiac surgery, which leads to increased length of hospital stay. Left atrial imaging to quantify the amount of scar –and concurrent stiffness--in the left atrium of the heart might be an indicator of which patients will develop this arrhythmia. This project seeks to develop a new method for imaging during free-breathing, and use this in patients before and after surgery to test whether increased atrial scar is an indicator of developing the arrythmia.